Regulation of Mesenchymal Progenitor Cell Fate and Adipose Tissue Remodeling

SUMMARY
Metabolic diseases are rising around the world as changing diets have led to striking increases in obesity
rates. Co-morbidities including coronary artery disease and type 2 diabetes drive massive increases in
medical costs and are leading causes of death worldwide. Adipose tissue is crucial for safely sequestering
lipids to protect other organs as obesity progresses. Unhealthy expansion of adipose tissue due to genetic
or environmental factors leads to increased inflammation and drives the progression of metabolic disease.
Therefore, understanding the adipose tissue remodeling process in response is crucial for the development
of novel therapies to promote metabolic health and reduce chronic inflammation. Mesenchymal progenitor
cells (MPCs) are a heterogeneous cell population in adipose tissue that respond to environmental and
metabolic cues to regulate various processes including adipogenesis, immune cell activity and fibrosis.
We have found that during obesity progression, MPCs undergo a cell fate switch into cells with properties
similar to cancer associated fibroblasts (CAFs). This CAF-like population expresses hallmark CAF genes
including the transcription factor SOX4 and the pleotropic growth factor Midkine (MDK) that likely regulate
adipogenesis and inflammation in adipose tissue. Importantly, both SOX4 and MDK levels correlate with
type 2 diabetes status in humans. Our central hypothesis is that the induction inflammatory CAF-like cells
in adipose tissue promotes maladaptive inflammation and decreases proper adipose tissue function.
Specific Aim 1 investigates the role of the transcription factor SOX4 in driving MPC phenotype switching
and adipose tissue remodeling during the development of obesity and insulin resistance. Specific Aim 2
investigates the role of MDK in regulating immune cell activity and adipose tissue function. Overall, these
studies will provide insight into how adipose tissue remodels during the development of obesity, leading to
an unhealthy metabolic profile and systemic inflammation that can drive the progression of cardiometabolic
complications and other pathologies. Understanding these processes may uncover new therapeutic
strategies for metabolic disease.

Public health relevance
Narrative Obesity drives the development of fibrotic and inflammatory mesenchymal cells in adipose tissue with similarity to cancer-associated fibroblasts. This project applies state-of-the-art techniques to understand adipose tissue remodeling responses in obesity, with a focus on mesenchymal progenitor cells, with the goal of identifying novel therapeutic targets to ameliorate metabolic and fibrotic diseases.